Quantitative dissection of the events that encode bone size and shape during regeneration

ABSTRACT
Mammals possess a limited compacity to regenerate appendages following traumatic injury and amputation,
including regenerating digit tips and healing of bone fractures. In contrast, zebrafish can regenerate entire
appendages following amputation. As in development, regenerated appendages are scaled appropriately to
body size. Extensive genetic and pharmacological experiments have established that canonical signaling
pathways, such as Fgf and Wnt, are reactivated following injury to promote the cell proliferation, migration, and
differentiation that drives regeneration of appendages. However, how these pathways encode size and shape
is unclear. This is due, in part, to the limited number of quantitative and dynamic descriptions of these signaling
pathways and their downstream cellular events during regeneration. To address these gaps in the
understanding of appendage scaling during regeneration, this proposal aims to develop a quantitative, live
imaging platform for zebrafish caudal fin regeneration. Specifically, Aim 1 will determine the role of extracellular
signal-regulated kinase (ERK) in encoding cell proliferation and bone size during fin ray regeneration. Aim 2
will define the role of negative feedback during fin regeneration and investigate whether this negative feedback
contributes to the robustness of this regeneration event. Collectively, this work will establish a quantitative
model for interrogating the cellular basis of size and shape control during regeneration. This work will be
conducted at Duke University under the mentorship of Dr. Di Talia and Dr. Poss. This is a highly collaborative
training environment that affords expertise in quantitative and regenerative biology. This proposed research
will be carried out alongside focused training in quantitative approaches, scientific writing, and mentorship.

Public health relevance
PROJECT NARRATIVE Unlike mammals, zebrafish possess the ability to regenerate entire appendages following traumatic injury, such as amputation, and these regenerated appendages faithfully recapitulate the size and shape of the original appendage. How size and shape are encoded during appendage regeneration in unclear, in part because there is an incomplete dynamic and quantitative understanding of the cellular events that underlie regeneration. This proposal will quantitatively define the dynamic molecular and cellular events that promote zebrafish appendage regeneration and uncover molecular events that are potential therapeutic targets for enhancing appendage regeneration in humans.